Molecular mechanisms underlying reduced vitamin C transport process in Alzheimer's disease and its impact on neuroinflammation

PROJECT SUMMARY
Alzheimer’s disease (AD) is a major cause of age-related dementia. The underlying mechanisms are not well
understood, but oxidative damage is a key component in AD pathogenesis. Vitamin C (vitC) is a powerful anti-
oxidant that plays a major role in reducing oxidative stress and inflammation in the brain. AD subjects display a
deficiency in vitC and several studies support the role of this vitamin in protection against the onset and
progression of AD. Despite the beneficial effects of vitC on AD, what remains unknown are the underlying
molecular mechanisms that lead to a deficiency of vitC in AD and how this deficiency enhances inflammation
and pathogenesis of AD. VitC is an essential micronutrient that cannot be synthesized de novo or stored by the
body and must be obtained from diet source. VitC uptake occurs through a Na+-dependent carrier-mediated
process via sodium-dependent vitC transporters in the intestine (SVCT1 and SVCT2) and brain (SVCT2).
Studies have shown that vitC supplementation failed to slow the cognitive decline observed in AD despite high
dietary intake of vitC. The decreased absorption of vitC may be due to the reduced levels of expression of the
vitC transporters in these important organs. Our preliminary findings indicate that expression of these
transporters correlates inversely with advancing age in human and mouse brain and intestine. Further
investigations revealed that inflammatory cytokines could reduce the expression of the vitC transporters in these
organs. Neuro-inflammation, for example, has been implicated in AD pathology. When examining the effect of
vitC on inflammation, our studies revealed that the increased NLRP3 inflammasome expression in AD may be
regulated by vitC. Based on previous studies and our preliminary findings, we hypothesize that deficiency of
vitC due to reduced functional expression of the vitC transporters in the brain and intestine enhances
inflammation and promotes AD pathogenesis. The objective of this project is to investigate the molecular
mechanisms underlying vitC deficiency and the associated inflammation. To test this hypothesis, we propose
two specific aims: 1) to determine whether dysregulated intestinal vitC transport is responsible for decreased
vitC levels in AD and 2) to determine the mechanisms by which vitC deficiency enhances the expression of
NLRP3 and inflammation. We will use advanced in vivo mice models as well as state-of-the-art cell/molecular
biological approaches in this application. The long term goal of this project is to develop novel therapeutics for
reducing the severity of AD pathogenesis.

Public health relevance
PROJECT NARRATIVE Alzheimer’s disease (AD) is associated with high oxidative stress and deficiency of a major antioxidant, vitamin C. The present proposal seeks to understand the molecular mechanisms underlying the vitamin C deficiency in AD. The information gained from this study will aid us in the design of effective strategies to overcome the vitamin C deficiency and mitigate AD pathology.